Closing the loop with an automatic referral population and summarization system

In the United States, more than a third of patients are referred to a specialist each year, and specialist visits
constitute more than half of outpatient visits. Even though all physicians highly value communication between
primary care providers (PCPs) and specialists, both PCPs and specialists cite the lack of effective information
transfer as one of the most significant problems in the referral process. Therefore, it is critical to investigate a
new method to improve communication during care transitions. With their ubiquitous use, it is recognized that
electronic health records (EHRs) should ensure a seamless flow of information across healthcare systems to
improve the referral process. But, a lack of accessible and relevant information in the referral process remains a
pressing problem. Recently, emerging deep learning (DL) and natural language processing (NLP) methods have
been successfully applied in extracting pertinent information from EHRs and generating text summarization to
improve care quality and patient outcomes. However, existing technologies cannot be applied to process
heterogeneous data from EHRs and create high-quality clinical summaries for communicating a reason for
referral. Responding to PA-20-185, this project will develop and validate a novel informatics framework to collect
and synthesize longitudinal, multimodal EHR data for automatic referral form generation and summarization.
While the referring provider and specialist can be any type of provider for any condition, the focus in this
application has been on headache for primary care, because it is an extremely common symptom and affects
people of all ages, races, and socioeconomic statuses. More importantly, relevant information needed for
headache referrals has been defined in local and national evidence-based practice guidelines. Therefore, a
health information technology solution to make these data accessible will empower communication between
PCPs and specialists, which can improve the care of millions of patients suffering from disabling headache
disorders. Based on our preliminary data and our experience with an interdisciplinary team of data scientists and
physicians, we plan to execute specific aims: 1) Convert text-based guidelines into a standards-based algorithm
for electronic implementation; 2) develop models to automatically populate data from EHR and clinical notes to
fill the referral form; 3) create a framework to summarize the longitudinal clinical notes to fill out the referral form;
and 4) develop and validate the headache referral system with a user-centered design approach. The research
proposed in this project is novel and innovative because it will produce and rigorously test new solutions to
improve the communication between health professonals to ensure that safe, high-quality care is provided and
care continuity is maintained. The success of this project will (1) fill important gaps in our knowledge of
understanding the types of information exchange that will optimize patient care during transitions and (2) provide
evidence-based solutions to enable the exchange.

Public health relevance
Project narrative The proposed research is relevant to public health because it improves the quality of care and patient outcomes during care transitions. The new and improved health information technology solutions proposed in this project can facilitate an integrated multi-disciplinary approach to improving care transitions by defragmenting information, improving communication, and assuring the care team has access to reliable and complete health information that may be located in other care settings or disparate systems. The proposed research is also relevant to the part of the NLM’s strategic plan that focuses on enabling interoperability of clinical systems and meaningful use of electronic health records, and effective translation of new knowledge into practice.